Investigator Development Core

Program Summary – Investigator Development Core
Main goal: The main goal of the Investigator Development Core (IDC) is to support the development of post-
doctoral fellows, junior faculty, and early stage investigators in the area of prostate cancer research. The
objective of the program is to engage researchers across disciplines with an aim to promote interdisciplinary
collaborations, address prostate cancer disparities from a biological and social prospective. CCRTD members
have complementary and integrated expertise and demonstrated an ongoing record of accomplishments in the
area of prostate cancer research. The program will support 3 pilot projects per year selected from a strong
pipeline of pilot projects with a potential pool of prospective investigators (10-20) who require funding in order
to generate data for application to external granting agencies. A committee will assess the pilot projects before
funding the projects and the organized mentoring support will be provided to pilot project recipients in order to
promote success of their projects.
Significance: The proposed pilot projects are consistent with the NIH's Roadmap for Medical Research that
acknowledges the integration of behavioral and social science research with biological research in addressing
health disparities. The proposed activities in the Investigator Development Core will strongly support the
development and enhancement of the competitiveness of diverse investigators in basic biomedical and
behavioral sciences, particularly early-stage investigators. The proposed plan for soliciting and evaluating
research proposals, prioritizing projects, and monitoring their performance in achieving project goals will further
enhance the investigator development.

Public health relevance
Project Narrative – Investigator Development Core The Investigator Development Core (IDC) will support the development for competitive and diverse pilot research projects in basic biomedical and behavior sciences from early stage investigators and postdoctoral fellows and provide mentoring for pilot project recipients.